Radiomics approach to engineering an artificial intelligence based echocardiography platform to predict cardiovascular surgery and heart failure outcomes.

SUMMARY
In recent years, artificial intelligence has enabled automated systems to meet or exceed the performance of
clinical experts across a wide variety of medical imaging tasks, in applications ranging from disease diagnosis
using Chest X-Rays to survival analyses using histopathology slides. All current automated echocardiography
systems – much like human echocardiography reads – are inherently reductionist in nature; a complex sequence
and pattern of cardiac contraction is reduced to an outline of one or more chambers, from which a few global
metrics of heart function are then calculated. Despite the staggering increase in usable data, the vast majority of
information contained in time-resolved echocardiography videos remain woefully underutilized. As opposed to
treating echocardiography studies as videos intended solely for visual interpretation, the ‘radiomics’ approach
treats medical images as high-dimensional datasets to be mined with advanced computational tools. The overall
goals of this project are to further develop and validate our novel, generalizable, multi-modal artificial intelligence
(AI) platform for analyzing time resolved echocardiography studies, to address this underutilization.
The impact of such an ECHO AI system is immediately perceptible in the field of heart failure. An estimated 6.5
million people suffer from heart failure in the United States. Across the spectrum of severity in this disease,
echocardiography remains the cornerstone of screening and clinical diagnosis, a guide for medical management
and pharmacotherapy, and an essential tool for planning acute lifesaving surgical interventions. We propose to
build on our preliminary research and ready access to high quality paired echocardiographic and clinical datasets
to achieve the following goals: 1) Develop a surgical decision support system for end-stage heart failure patients
considered for left ventricular assist device (LVAD) implant. 2) Expand and generalize our ECHO AI tools to
enable downstream prediction of long-term survival and development of heart failure, in both asymptomatic
individuals and patients with pulmonary arterial hypertension 3) Cloud and hardware integration of our ECHO AI
platform. The end result of our research will be a powerful ECHO AI tool with that is translatable, and integrated
into clinical practice.

Public health relevance
NARRATIVE We propose to develop and validate a core echocardiography artificial intelligence platform designed to extract the full density of information present in a standard echocardiogram. Echocardiography is a ubiquitous imaging modality, and such a system has an immediate impact on how we manage heart failure – a disease that affects an estimated 6.5 million people in the United States alone. Using our ECHO AI platform, we propose to build tools for surgical decision support and survival forecasting in patients with heart failure, and early screening tools to identify individuals at high risk of developing heart failure in the future.